Vermont Center on Behavior and Health

This is a Phase 2 Center of Biomedical Research Excellence (COBRE) application to further develop the
Vermont Center on Behavior and Health (VCBH) at the University of Vermont (UVM). This multidisciplinary
research center focuses on investigating relationships between unhealthy behavior patterns (e.g., substance
abuse, physical inactivity, unhealthy food choices, non-adherence with recommended medical regimens) and
risk for chronic disease and premature death. The overarching scientific priorities are (a) increasing
understanding of the mechanisms underpinning vulnerability to unhealthy behavior patterns and (b) developing
more effective behavior-change interventions. Advances in each of these areas are essential to improving
U.S. population health, reducing health disparities, and curtailing spiraling health care costs. VCBH has made
considerable progress in Phase 1 towards establishing a productive center of research excellence in this
important area of biomedical research. VCBH currently consists of 20 UVM faculty members, highly
accomplished external, internal, and community advisors, and collaborators from other IDeA states and
beyond. The current faculty is multidisciplinary, evenly distributed across academic ranks, and highly
productive, having published 118 articles in peer-reviewed journals and obtained $59,135,320 in additional
external grant support during the initial four years of Phase 1 funding. We propose to continue prioritizing the
mentoring of promising early-career faculty in Phase 2. We provided nine early-career faculty members with
funded research projects and career-development support during Phase 1, using a multi-element mentoring
plan that we will continue evaluating and refining during the proposed funding period. We propose continuing
an Administrative Core that promotes effective communication, fiscal planning and oversight, supports a
vibrant intellectual infrastructure, and directs and supports efforts to obtain external grant support. We have
established two additional VCBH cores that we propose to continue, a Behavioral Economics and Intervention
Sciences (BEIS) Core and a Collaboration, Dissemination, and Education (CDE) Core. The BEIS assists
investigators with a decision-making and neuroimaging component to examine processes underpinning
vulnerability to unhealthy behavior patterns, development of behavior-change interventions, and economic
modeling of intervention cost-effectiveness. The CDE supports local, national, and international research
collaborations, dissemination of new knowledge through a monthly lecture series, annual national conferences,
annual Special Issues of the peer-reviewed journal Preventive Medicine, other publications, and educational
efforts including seminars and workshops in behavior and health that are offered on the UVM campus and
streamed live to collaborators and interested others. We are confident that continuing to develop and grow
VCBH following this overall management plan will succeed in establishing a multidisciplinary center of
research excellence in behavior and health with sustainable local, national, and international impact.

Public health relevance
NARRATIVE Many individuals persist in personal behaviors (substance abuse, physical inactivity/obesity) that significantly increase risk for chronic disease and premature death. This relationship between personal behaviors and disease risk is firmly established, but much remains to be learned about why certain individuals are more likely to engage in risky behaviors and how to promote behavior change.